Prenatal sleep and pathways to offspring cardiometabolic risk

Project Summary
Cardiovascular disease (CVD) is the leading cause of death in the US, with significant disparities by
socioeconomic status and race/ethnicity. The developmental origins of CVD begin early in life and even before
birth. Despite the known importance of early life for CVD risk, the processes and pathways by which early life
experiences shape CVD risk remain poorly understood. This proposal tests the hypothesis that prenatal sleep,
which is highly integrated with circadian rhythms and influences numerous physiological systems during
pregnancy, is an understudied pathway to poor child cardiovascular health. Existing evidence relying primarily
on subjective sleep assessments demonstrates a correlation between prenatal sleep and offspring CVD risk.
However, critical gaps in the literature that impede progress include: 1) lack of investigation of physiological
pathways by which prenatal maternal sleep impacts offspring CVD risk, 2) absence of rigorous and objective
measurements of prenatal sleep (e.g., actigraphy) longitudinally across pregnancy in the context of other
measures of maternal health, and 3) lack of dense longitudinal follow-up of infant growth and development. This
proposal investigates three key pathways that are both known to be impacted by prenatal sleep and linked to
CVD risk will be examined: maternal biological processes (stress-mediating and inflammatory pathways), child
biological processes (infant growth trajectories, adiposity) and child behavior (sleep, negative emotionality, self-
regulation). To investigate these pathways, three aims will be tested. Aim 1 tests the hypothesis that prenatal
maternal sleep trajectories predict prenatal maternal biological pathways that may influence offspring CVD risk,
including increased circulating inflammatory biomarkers and altered diurnal salivary cortisol during each trimester
of pregnancy. Aim 2 tests the hypothesis that prenatal maternal sleep trajectories predict offspring biological
pathways to CVD risk, including accelerated offspring growth trajectories and greater body fat percentage
through 6 months postnatal. Aim 3 tests the hypothesis that prenatal maternal sleep trajectories predict offspring
behavioral contributors to CVD risk, including infant sleep, negative emotionality, and self-regulation. Aims will
be evaluated in a sample of 300 primarily low-income and racially- and ethnically diverse English- and Spanish-
speaking pregnant individuals from Denver Health Hospital Authority, a community safety-net hospital that serves
the largest proportion of uninsured and Medicaid patients in the Denver area.

Public health relevance
PROJECT NARRATIVE Despite increasing awareness that cardiovascular disease (CVD) has prenatal origins, we remain limited in our understanding of early life processes and pathways that contribute to CVD risk and modifiable targets for early prevention and intervention. This proposal addresses existing knowledge gaps by identifying the contribution of prenatal maternal sleep to offspring CVD risk by characterizing maternal biological processes and infant biological and behavioral processes that contribute to CVD risk. The discoveries generated by this project promise the potential to elucidate new early-intervention targets, in line with both American Heart Association impact goals and NHLBI strategic goals of preventing CVD early in life.